ROLE OF CYTOSKELETON IN OOCYTE MEIOTIC MATURATION

The present revised proposed is focused on elucidating the mechanism of oocyte nucleus migration (GVM) which occurs during the progestogen-induced prophase I-metaphase I transition of meiosis. A second major goal is to compare maturation changes induced by progestogens with those elicited by Insulin-Like-Growth Factor I (IGF I). Comparison of cytoskeletal protein changes and electrophysiological parameters (membrane voltage, resistance and current) will be made between the two treatment groups. The conversion of the oocyte to the fertilizable egg is critical for normal fertilization and subsequent normal development of the individual. Since this conversion is so basic to the formation of the individual, abnormalities at this level may play a role in producing health disorders at subsequent developmental stages. Fundamental questions addressed include: 1) What mechanism is responsible for nuclear movement?; 2) How is this movement related to cytoskeletal changes during cell division; and 3) How do hormones and growth factors cause changes in the cytoskeleton? The large size of both the oocyte and its nucleus along with the ease of microelectrode insertion and microinjection into these special cells allows experimental investigation of the cytoskeleton, GVM and measurement of electrophysiological parameters. Microinjection will be used to enhance fixation of oocyte ultrastructure for analysis at the EM level. Specific antibodies to cytoskeletal proteins will be microinjected to "dissect" the role of different cytoskeletal components during steroid-induced meiotic reinitiation. These approaches will be complemented by the use of immunogold, silver-enhanced microscopy to follow overall changes in cytoskeletal components during meiosis and germinal vesicle dissolution (GVD) in oocytes. In the long term, the cytoskeletal proteins contained in soluble and insoluble fractions of oocytes undergoing meiotic maturation will be identified and characterized by the techniques of gel electrophoresis and immunoblotting. These studies, which use a variety of techniques in an integrative way, will further our understanding of changes in oocyte architecture during the important developmental events resulting in the conversion of the oocyte to a fertilizable egg.